Enhancing the Force Validated Heart Valve Surgical Planning Tool

ABSTRACT
While advances in cardiac surgery have revolutionized the treatment of heart valve disease, problems remain
with the durability of surgical repair techniques, devices and replacement valves. A major challenge in
perfecting the design of these procedures and devices is to ensure that post-operatively the valve functions
under the lowest possible stress to ensure its longevity. This is particularly true for the mitral valve, which faces
the highest pressures and forces of the four cardiac valves. The force is equal to two regular bottles of water in
gravity, 100,000 timers per day. The seriousness of the problem is dire; according to recent American Heart
Association reports, recurrence of moderate to severe insufficiency at 12 months following surgical repair of
ischemic mitral valve regurgitation is still more than 30%.
While information for surgical planning or device design can be based on computer simulations built from
available medical imaging modalities with assumed or measured material properties of the heart and valve
tissue, these material properties are often associated with significant simplifications and thus the simulation
may not accurately reflect the true forces and strains on the cardiac valves. The goal of this work is to build
upon the success of the first phase of the project, and demonstrate use of a new, force-validated model of the
human mitral valve for patient-specific surgical planning and intelligent device development, using nature’s own
stress-minimization concepts. We hypothesize that constructing computational models using experimental
force and shape measurements obtained from both healthy porcine and human valves will result in a more
precise system for surgical planning, device development, and FDA device approval.
The porcine mitral valve has for more than three decades been accepted as a highly relevant anatomic basis
of the human mitral valve. Within this project, we will obtain images from both human and porcine hearts to
obtain the geometry of major valve landmark points, then explant the heart from the animal / donor, and mount
the dissected mitral valves in a valve-specific dedicated holder that is 3D printed to match each animal and
human’s individual anatomy. The mitral valve will then undergo high resolution 3D imaging while allowing the
valve to remain open and closed under physiological conditions. Detailed force measurements will be
performed on the same valves to ensure that correct biomechanical boundary conditions are obtained. These
high-resolution data will then inform a computational model of the valve that will be tested and validated
against the clinical measurements obtained in vivo prior to heart explantation. At the conclusion of this project
we will employ the model in one exemplary mitral valve repair surgery to demonstrate the significant advantage
of force validated computational models and show the hypothesized self-supporting capabilities of the valve.
The project participants’ competencies are interdisciplinary and highly relevant to the project. Expertise is
brought together from cardiovascular experimentation, clinical work, and computational modeling.

Public health relevance
NARRATIVE This work aims to demonstrate the self-supporting capabilities of the mitral heart valve in a new force-validated model of the valve that utilizes nature's stress-minimization principles for enhanced longevity of interventions. By using both porcine and human mitral valves in a patient-specific partially 3D-printed chamber, the collected data will inform a computational soft tissue model, ensuring the relevance of stress conditions in the left heart for intelligent surgery planning and device advancement in treating heart valve disease.